Workshop on Statistical Genetic Methods for Human Complex Traits

PROJECT SUMMARY
This proposal requests a further five years of funding to support the organization and delivery, on five
occasions, of a one week intensive training workshop focused on the development of skills in statistical
genetics that will advance the mission of NIMH. The workshop is targeted at post-doctoral trainees, graduate
and medical students (MDs and PhDs), and early career faculty carrying out mental health research supported
by the Public Health Service, who are currently conducting or planning to initiate research on the genetics of
complex traits involved in mental health. So as to keep a balance between the needs of investigators
conducting different kinds of studies and those using a variety of methodologies, we propose to alternate
between a workshop focusing on structural equation modeling of twin, family, multivariate, and developmental
data, and a workshop focusing on the analysis of genome variation including sequence data. Since the
inception of the workshops in 1987, there have been over 2000 registrations for this training. Twenty four of the
31 workshops have been hosted by the current PI (John Hewitt) in Boulder, Colorado. Although a training
workshop, it shares some characteristics of a scientific meeting. Participants are encouraged discuss their
current research, to bring copies of their data to work on directly while at the workshop, and to discuss and
develop research plans. New collaborations are established to facilitate both high quality research and
publication on existing data sets, and new research initiatives are strengthened by the collaboration of experts
with a phenotypic focus with experts in methodology. The curriculum of the workshop is continuously updated
by world leaders in statistical and computational genetics and their application to mental health. This proposal
follows the guidelines in PA Number: PAR-17-082 for Short Courses for Mental Health-Related Research
Education and extends the training work previously funded by grants T35MH19392, T35MH19918, and
R25MH019918. Through both didactics and hands-on experience, research scientists participating in the
workshops will refine their research skills in genetic and genomic design and analysis. The workshop offers an
innovative educational program designed to provide education in state-of-the-art statistical genetic methods
important to fulfill the objectives of the current NIMH Strategic Plan, including its first Strategic Objective: to
define the mechanisms of complex behaviors, in particular through the research priority of identifying the
genomic and non-genomic factors associated with mental illnesses.

Public health relevance
PROJECT NARRATIVE This research education meets the need for training in methods of statistical genetics for mental health researchers working with genome wide association studies, next generation sequencing studies, and twin and family studies of genetic and environmental influences on mental illnesses. The introduction of new techniques of statistical and computational genetics, and the increasing interest in the methodology for identifying the genes influencing complex traits, has created an enormous demand for this training.